The relationship between neuronal activity and stroke

Stroke is the one of the leading causes for death and the leading cause of long-term disability in the USA,
and most strokes originate from blood flow blockage known as ischemic stroke. Since the majority of cortical
ischemic strokes originate from blockage in the middle cerebral artery (MCA), our lab has studied stroke
protection in a rat model of permanent middle cerebral artery occlusion (pMCAo). Our findings have
demonstrated that sensory stimulation in the early 2 hours following pMCAo is protective but later (3-4 hours)
the same stimulation becomes damaging (known as infarct). It is assumed that the location and volume of either
the damaged or protected territory depends on the spatial structure of the occluded artery (e.g., MCA), but
research results in our lab point to an alternative hypothesis that the location and volume of an infarcted or
protected territory depends on the spread of evoked neuronal activity in cortex.
To address our hypothesis, we plan to apply state-of-the-art multi-modal battery of in vivo wide-field imaging
techniques including blood flow imaging and functional imaging of cortical activity. These imaging techniques
are complemented by optogentic stimulation, electrophysiological recordings using microelectrode arrays,
histological, pharmacological treatment studies, and by the development of machine learning algorithms.
These techniques will be employed to provide an unprecedented spatiotemporal, quantitative understanding
on how the spread of evoked activity is pivotal for predicating the location and volume of the infarcted or
protected cortical territory. Finally, to increase the translational potential of these studies, these techniques
will be applied in old rats that represent the population most vulnerable to stroke, and in awake, head-fixed
young and old rats to increase the translational potential of our research.

Public health relevance
Stroke is one of the leading causes of death and the leading cause of long-term disability in the USA, and most of strokes originate from blood flow blockage known as ischemic stroke. This proposal seeks to elucidate how the spread of evoked activity in cortex predicts the location and volume of stroke protection and stroke damage in animal model of ischemic cortical stroke. We propose to apply a battery of the state-of-the- art multimodal techniques that will enable detailed quantitative studies of our hypothesis, which has clear translational potential.